Myeloid Cells: Roles in Different Tissue Microenvironments

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Myeloid Cells: Roles in Different Tissue
Microenvironments organized by Drs. Irina A. Udalova, Ana-Maria Lennon-Duménil and Paul Kubes, with
scientific programming input from Keystone Symposia. The meeting will take place March 3–6, 2025 at
Herrenhausen Palace, Hannover, Germany.
Myeloid cells are essential components of the innate immune system and play a key role in the pathogenesis of
many diseases. Myeloid cell roles are well characterized, but how myeloid cell responses are shaped by the
local tissue microenvironment, including interaction with other cells, mechanical and osmotic influences,
represents an important frontier area in the field. This meeting was designed to address the different mechanisms
underlying signaling, epigenetic and metabolic adaptations of myeloid cells to their environments. The
programmatic sessions aim to better integrate biochemical and biophysical concepts with more traditional
immunological and genomic views of myeloid cells. The program will provide a forum for the sharing of new
discoveries and the exchange of expertise, highlighting the latest tools, technical developments and resources
that are available to study the diversity of myeloid states in various contexts. This meeting will bring together
groups of scientists who normally would attend more specialized meetings and thus, will contribute to the growth
of an interdisciplinary community focused on advancing the study of myeloid cell biology.

Public health relevance
PROJECT NARRATIVE Myeloid cells are primary components of the innate immune system, which serves as the first line of defense against infection, but they also help build long-lasting adaptive immune responses. While myeloid cell development, diversity and biological functions are well characterized, there remains a substantial knowledge gap in the roles that various tissue microenvironments play in shaping myeloid cell actions. This meeting will explore these complex interactions by bringing together interdisciplinary groups of scientists to share recent results, new technologies and emerging concepts that will propel the field forward.